Sin Duda: a community-driven approach to expand reach, access and uptake of COVID-19 home-based tests for at risk Latinos

The COVID-19 pandemic disproportionately impacts Latinos in the US. COVID-19 testing remains critical for
tracking and slowing the spread of the virus and preventing future outbreaks, particularly in communities
disproportionately affected by COVID-19 and where vaccination coverage is suboptimal. The goal of this
project is to expand our RADx-UP Phase 1 COVID-19 testing project "Vive Sin Duda" to implement and
evaluate innovative implementation strategies to increase reach, access, and uptake of COVID-19 homebased self-testing (HST) among low-income Latinos in Maryland. We will implement and evaluate two COVID19 HST distribution approaches: 1) Network-based; and 2) Social marketing. We will also incorporate data driven iterative changes to optimize a community health worker (CHW)-led short message service (SMS)
platform to support HST and linkage to COVID-19 care, vaccination, and other services (e.g., cash and food
assistance). Primary and secondary outcomes include: 1) Reach and uptake of HST; and 2) Linkage to care
for those who test positive or vaccination for unvaccinated people who test negative. Leveraging our existing
community coalition, testing and vaccination clinics, and a team of bilingual and bicultural CHWs, we are well poised to implement a COVID-19 HST program and measure its impact. Our research will provide important
new information that will improve access and uptake of innovative COVID-19 testing technology. It also will fill
critical knowledge gaps to guide the translation of evidence-based interventions into widespread adoption by
RADx-UP consortium members.

Public health relevance
PROJECT NARRATIVE The proposed study is relevant to profound disparities in COVID-19 among Latinos communities. This proposal will implement and evaluate innovative implementation strategies to increase reach, access, and uptake of COVID-19 home-based self-testing (HST) among low-income Latinos in Maryland. This proposal provides important new information that will improve access and uptake of innovative COVID-19 testing technology.